Regulation of HDV life cycle by the immune response to HBV infection

Abstract
Hepatitis delta virus (HDV) is a sub-viral agent of hepatitis B virus (HBV). It uses HBV envelope proteins (or
surface antigen, HBsAg) to form its virions and infect hepatocytes via HBV receptor. About 257 million people
worldwide are chronically infected with HBV, of which ~20 million are also chronically infected with HDV. HDV
infection causes additional liver damage, and may accelerate liver disease, cause more rapid and frequent
cirrhosis, and increase risk of hepatocellular carcinoma. Anti-HBV drugs do not block HDV infection, and no
drugs exist in clinic that directly target HDV. Mechanism of HDV infection is not fully understood, which affects
the treatment options. HDV-HBV and HDV-host interactions are complex and under-studied. The regulation of
HDV life cycle by the immune response to HBV infection is practically unexplored, and it is the subject for this
study. Thus, HBV-host interactions lead to emergence of the immune escape mutations (IEMs) in the major
antigenic loop (MAL) of HBsAg. IEMs can make HBsAg poorly recognized by natural anti-HBsAg antibodies
and undetectable by the immunoassays, cause HBV vaccine failure, facilitate re-infection of grafted liver with
HBV, and promote maintenance of chronic HBV infection. IEMs can profoundly affect secretion of HBsAg and
HBV virions. However, the understanding how IEMs affect HDV assembly and infectivity, and recognition of
HDV by anti-HBsAg antibodies (i.e., HDV antigenicity) is very limited, and the vast majority of IEMs were not
analyzed in this respect. We found that HBsAg regulates HDV infectivity by facilitating two distinct functions
that could be functionally separated. It determines the number of the infected hepatocytes by regulating the
attachment/entry. It also determines the number of HDV genomes that post-entry reach the nucleus and start
the replication by regulating the trafficking and uncoating (loss of the envelope in infected cell). Our work
suggested that the virus infectivity, spread and super-infection are likely critical factors for the establishment
and maintenance of chronic HDV infection. In addition, the rate of HDV assembly can greatly affect HDV
spread/super-infection. The amino acids in MAL can affect HBsAg yield/secretion, and thus can affect HDV
assembly. MAL is expected to regulate the (i) attachment/entry and (ii) possibly trafficking/uncoating, and thus
to regulate HDV infectivity. MAL also regulates the recognition of the virions by anti-HBsAg antibodies. Thus,
our central hypothesis is that IEMs could considerably affect the assembly, infectivity and antigenicity of HDV.
Aim 1 using HBsAg of HBV genotypes A-D (for which most IEMs were reported) will find how HBsAg bearing
IEMs can regulate the yield of secreted HDV virions and affect the recognition of HDV virions by hepatitis B
immune globulin (HBIg). Aim 2 using the above mentioned HBsAg bearing natural IEMs will find how IEMs can
regulate the infectivity of HDV virions. The proposed study will considerably advance our understanding of the
mechanisms by which the host regulates (i) HDV-host interactions, (ii) HBV-HDV interactions, (iii) assembly
and infectivity of HDV, and (iv) HDV persistence via facilitating the emergence of IEMs in HBsAg.

Public health relevance
Project narrative The proposal will examine how the anti-HBV immune response regulates HDV infection, which currently remains practically unexplored area. It will investigate the mechanisms of how the immune escape mutations (IEMs) in HBsAg that emerged as a result of anti-HBV immune response regulate the assembly and infectivity of HDV, and HDV recognition by anti-HBsAg antibodies. It is expected that the proposed study will considerably advance our understanding of how (i) HDV-host interactions, (ii) HBV-HDV interactions, and (iii) persistence of HDV are regulated by the host through the facilitating the emergence of IEMs in HBsAg.